Core C: Biostatistics and Data Management

Project Summary/Abstract
The Biostatistics and Data Management (BDM) Core is responsible for all statistical and data
management activities for each of the Myeloproliferative Neoplasm Research Consortium
(MPN-RC) projects including all clinical trials. Each of the projects presented in this application
reflects input from the Director of the BDM Core (Dr. Amylou Dueck, Mayo Clinic) on the design,
data management, and biostatistical analysis plan. The BDM Core is constituted to provide
state-of-the-art statistical collaboration and data management support to all clinical and
translational research projects. The biostatistical and data management components of this
Core are integrated at Mayo Clinic under the leadership of Dr. Amylou Dueck, who is also the
Director of the Biostatistics Shared Resource of the entire Mayo Clinic Cancer Center which
spans across Minnesota, Arizona, and Florida. The Core will provide statistical expertise
including experimental design for laboratory studies, statistical modeling, analysis of high-
dimensional data, analysis of patient-reported outcomes, design and analyses of correlative
studies using biospecimens, and sound clinical trial design, monitoring, and analysis. The Core
will also provide state-of-the-art web-based data management through Mayo Clinic's data
management infrastructure with all clinical trial, biomarker, and tumor bank data captured in
Medidata Rave. This web-based system provides ease of use coupled with an integrated
randomization module (Medidata Balance), app-based electronic patient questionnaires
(Medidata Patient Cloud), custom reporting, robust data validation routines, and straightforward
integration with SAS for seamless overall statistical analysis. Dr. Dueck is an experienced co-
investigator on translational and clinical research program grants in hematologic malignancies
with extensive collaborations with the MPN-RC investigators. The competencies of the
biostatistical and data management components of this Core provide the full spectrum of
expertise and operational capacity needed to actively collaborate with the translational and
clinical investigators in the formulation of the research protocols, in implementation according to
internationally-accepted requirements, and in the statistical analysis of the data from clinical,
laboratory, and translational studies. The BDM Core is a critical component of the MPN-RC.

Public health relevance
Narrative The Biostatistics and Data Management Core will provide the Myeloproliferative Neoplasm Research Consortium (MPN-RC) investigators access to state-of-the-art integrated statistical and data management resources. It provides a mechanism for consistent and compatible data handling and tracking among the projects and ensures the work across the MPN-RC is accomplished in a timely manner and with the utmost statistical rigor. Providing oversight of all MPN-RC related statistical and data management activities through this Core allows for synergies and efficiencies for systemic and programmatic initiatives beyond what can be achieved with individual statistical teams for each project.